Multimodal, Multi-scale Framework for Ethical AI Model Development

Addressing healthcare disparities and improving precision medicine requires moving beyond race-based
medical models. Current clinical algorithms often overlook the full spectrum of patient diversity,
including biological, social, and environmental factors, leading to biased and inaccurate predictions. This
is evident in diseases like breast and prostate cancer, where disparities persist despite advancements in
treatment. Our proposal aims to address these gaps by developing novel digital phenotypes through the
integration of multimodal datasets—imaging, pathology, electronic health records (EHR), and social
determinants of health (SDOH). Leveraging advanced techniques in radiopathomics extraction, data
fusion, novel graph architectures, and unsupervised clustering, we aim to discover biologically relevant
patient populations to improve risk stratification and treatment optimization.
To achieve this, we will first develop an open-source fusion framework for multimodal data integration.
This robust framework will be incorporate tools for data harmonization, radiopathomics feature
extraction, multimodal data embedding, and graph neural networks. We will apply this framework to
discover biologically relevant digital phenotypes for breast and prostate cancer, and train phenotype-
specific risk prediction models which will be robustly validated at 4 external sites.
Our proposal emphasizes an ethical AI framework that incorporates privacy, fairness, accountability, and
inclusivity principles throughout the model development process. We will adopt an iterative model co-
development approach, engaging multidisciplinary stakeholders, including physicians, collaborators, and
industry partners, to continuously refine our data and models. This co-design process ensures that our
models remain clinically relevant, ethically sound, and aligned with the needs of diverse patient
populations.

Public health relevance
Each year in the United States, about 317,000 women are diagnosed with breast cancer and 314,000 men with prostate cancer. Among those treated, most do not benefit as intended: nearly four in five breast cancer patients given neoadjuvant chemotherapy still have residual disease at surgery, and nearly one in three men recur within ten years of definitive prostate therapy. Current tools miss these patients because today's molecular assays compress a tumor into a single-scale signal and existing models fail to generalize across sites. Multimodal fusion of the imaging, pathology, and clinical data that hospitals already collect captures complementary information no single modality holds, and MEFINDER delivers harmonized, reusable tooling so that a patient is reliably classified as low or high risk regardless of dataset or tools applied, enabling confident treatment decisions.